The influence of neighborhood factors and social determinants of health on OUD treatment outcomes

Abstract. Baltimore City is facing a significant health crisis surrounding rampant use of illicit substances such
as opioids. Opioid use disorder (OUD) continues to be a significant public health problem in the city with
overdoses continuing to surge. Poor access to care for OUD is contributing to the OUD national crisis, and
medications for opioid use disorder (MOUD) such as methadone have been shown to be life-saving medication.
Despite the availability of MOUD, there are many challenges in retention in treatment for OUD in urban cities like
Baltimore. The parent award (R33DA057747; PI: Magidson) is innovatively designed to improve treatment
retention in a Baltimore-based treatment program for OUD using a peer-delivered behavioral intervention (“Peer
Activate”). This proposal will supplement the parent award by examining how neighborhood factors and social
determinants of health influencetreatment outcomes of OUD and howthese neighborhood factors may moderate
the effect of the Peer Activate intervention on retention. The aims of the study include: 1) understand
neighborhood-related factors that impact methadone treatment retention; and 2) examine how neighborhood
factors may moderate the effectiveness of Peer Activate and how the intervention may be adapted to address
these factors in future work. For Aim 1, 30 study participants that received the Peer Activate intervention will be
recruited for semi-structuredinterviews, and the interviews will include questions revolving around environmental
structures of the neighborhood surrounding the treatment clinic, drop out, and relapse, and how they contribute
to low retention in treatment for OUD and how these neighborhood characteristics increase challenges in
recovery. Aim2 will use an observational quantitative assessment tool (NIfETy) to collect observational data from
the surrounding community, including social disorder (e.g., loitering), physical disorder (e.g., broken windows),
physical layout, and violence, alcohol, and drug use indicators. Candidate. This supplement award will support
an exceptional candidate, Ms. Anane, who is a first generation Black/AfricanAmerican woman, Flagship Fellow
at UMD and third-year public health doctoral candidate. The supplement will support her career goals by gaining
skills in research methods that incorporate neighborhood factors and environmental context into clinical trial
designs. She will receive additional mentorship and training from expert co-mentors in this area and will attend
training workshops and seminars, including GIS for Humanities and Social Sciences and Modern Statistical
Learning for Observational Data. The findings from this supplement grant proposal will inform the candidate’s
dissertation research and prepare her for a NIH T32 training grant for post-doctoral research. This research will
make a unique contribution to understanding the influence of neighborhood-related factors to treatment retention
for low-income, largely ethnic/minority individuals in a methadone maintenance program and understanding
neighborhood factors that are often ignored in behavioral clinical trials that may affect the outcomes of a peer-
delivered behavioral intervention in the parent award.

Public health relevance
Project Narrative Opioid use disorder (OUD) continues to be a significant problem in urban areas disproportionately affecting lower income and minoritized populations. The findings from this study will provide an understanding of the neighborhood characteristics of urban communities and their influence on treatment outcomes for OUD. The findings from this study can contribute to future research and interventions that will focus on the larger and systematic issues prevalent in urban communities that impact OUD treatment retention.